Defining the Regulatory Function of SOX2 in Squamous Cell Carcinoma

Project Summary/Abstract
Squamous cell carcinoma (SCC) is one of the most common cancers worldwide, with over one million deaths
annually. While treatments such as chemotherapy and radiation are available, their severe side effects highlight
the need for targeted therapies. SCCs from diverse tissues often share the overexpression of the transcription
factor SOX2, which has been implicated in tumor initiation and maintenance. Despite its central role in SCC,
therapeutic targeting of SOX2 remains challenging, necessitating a deeper understanding of its oncogenic
transcriptional program and regulatory mechanisms. Our preliminary work demonstrates that SOX2 acts
primarily as a transcriptional activator in SCC, binding promoters and distal enhancers to upregulate cancer-
relevant genes via chromatin loops. Interestingly, many SOX2 binding sites are co-occupied by the oncogenic
transcription factor TP63, a known master regulator in SCC. TP63 also functions as a pioneer factor, opening
chromatin to facilitate binding by other factors including SOX2. Despite their established co-regulatory role, little
is known about the mechanisms by which SOX2 and TP63 interact to regulate target gene expression in SCC.
We hypothesize that SOX2 and TP63 co-occupy enhancers and upregulate target genes driving
oncogenic pathways in SCC. This study aims to elucidate the functional regulatory role of SOX2 in SCC by
addressing two key aims. First, characterizing the cancer-specific transcriptional program regulated by SOX2.
Using an integrated genomics approach combining CRISPR-Cas9-mediated SOX2 knockout RNA-seq, SOX2
ChIP-seq, and H3K27ac HiChIP, we will identify direct SOX2 target genes. We will then prioritize genes relevant
to human SCC using data from the Cancer Genome Atlas. We will evaluate the role of these prioritized target
genes in cell proliferation and tumor growth using an in vitro competition assay and in vivo xenograft models.
Second, we will explore the interplay between SOX2 and TP63 at shared enhancer binding sites. We hypothesize
that TP63 facilitates chromatin accessibility, enabling SOX2 binding, and together, they regulate critical
oncogenic pathways. This will be tested using CRISPR Cas9-based enhancer motif disruption, and RNA-seq
and ATAC-seq following TP63 knockout to assess changes in chromatin accessibility and gene expression. This
work will reveal SOX2 target genes, and how SOX2 along with TP63 drives SCC, providing insights into
cancer-specific pathways that could serve as therapeutic targets. Furthermore, the insights gained may
extend to other cancers where SOX2 activation is implicated, broadening the impact of this work.

Public health relevance
Project Narrative This research will advance fundamental knowledge of how the transcription factor SOX2 drives squamous cell carcinoma (SCC), a highly prevalent cancer with significant mortality. By identifying cancer-specific pathways regulated by SOX2 and its co-regulatory function with TP63, this work aims to uncover actionable therapeutic targets that could lead to more effective and less toxic treatments for SCC. Furthermore, these findings may have far-reaching implications for other SOX2-driven cancers, broadening our knowledge of underlying oncogenic mechanisms.